Acetylcholine determines dopamine's role in learning versus moving

Project Summary
The neuromodulator dopamine is implicated in most neuropsychiatric disorders, and also several movement
disorders. A wealth of data has implicated dopamine release in the striatum -the input structure of the basal
ganglia- in both learning and motor control. Therefore, a major outstanding question for the field is understanding
how dopamine can satisfy these dual functions within the same brain area, using the same neural machinery.
For the most part, previous studies have either focused on movement or learning in separate experiments. The
proposed work has two main goals: (1) to relate dopamine release in the striatum to both learning and motor
control on single trials in the same animal, at task events occurring at distinct timepoints; (2) to test the hypothesis
that the neuromodulator acetylcholine dynamically gates whether dopamine in the striatum is used for learning
or moving on a moment-by-moment basis.
This proposal will use a novel behavioral paradigm in rats; critically, the task involves several sequential
events on single trials that differentially elicit movements, or convey information about offered rewards, enabling
dissociation of motor and reward-related dynamics at distinct timepoints. High-throughput behavioral training will
generate dozens of trained subjects for experiments in parallel, accelerating the rate of research progress. We
will use optical dopamine sensors to measure release in the striatum at distinct timepoints, testing the hypothesis
that dopamine promotes learning versus moving at distinct timepoints (Aim 1). We will also perform
electrophysiological recordings in the striatum to identify neural correlates of learning (i.e., neural plasticity) at
certain timepoints but not others (Aim 1). We will next use optogenetics to manipulate dopamine release at
distinct timepoints, and evaluate the effects on learning versus moving (Aim 2). Finally, previous experiments
suggest that another neuromodulator in the striatum, acetylcholine, might influence the effect of dopamine on
neurons. We will use optical methods to measure and manipulate acetylcholine at specific trial events and
evaluate effects on trial-by-trial learning and movement (Aim 3).
These experiments will test the hypothesis that acetylcholine gates whether striatal dopamine is used for
learning or moving. This will address a major outstanding question in the field: how can dopamine support
multiple distinct functions via the same circuit elements? Neuromodulatory systems including dopamine and
acetylcholine are implicated in myriad neuropsychiatric disorders including schizophrenia and depression. A
greater understanding of the circuit mechanisms by which they coordinate different aspects of behavior holds
promise for revealing novel therapeutic targets for these disorders.

Public health relevance
Project Narrative Midbrain dopamine neurons densely innervate the striatum, and this projection is thought to be critical for reinforcement learning as well as motor control. This proposal will combine behavioral, computational, circuit perturbation techniques and optical neuromodulatory sensors to test the novel hypothesis that the neuromodulator acetylcholine dynamically gates whether dopamine drives learning or moving. All neuropsychiatric disorders, including schizophrenia and bipolar disorder are thought to reflect dysfunction of the dopamine system, and are characterized by aberrant reward processing and disordered decision-making.